Pilot Projects Program

PILOT PROJECTS PROGRAM
SUMMARY/ABSTRACT
The Cardiorenal and Metabolic Diseases Research Center (CMDRC) at the University of Mississippi Medical
Center (UMMC) developed a highly successful Pilot Projects Program (PPP) during Phases 1 and 2 of COBRE
support. Over the past 9 years, the CMDRC PPP has provided funding, mentoring, core services, and
enhanced research infrastructure for 24 pilot grant investigators. The success of this program is highlighted by
~$26.92 million dollars in extramural funding obtained by previous PPP awardees as well as 459 papers
published in leading journals in the field, 15 book chapters and 286 presentations at international and national
meetings. To amplify the research base developed in Phases 1 and 2, the Phase 3 PPP will continue to
support innovative research in the areas of cardiorenal and metabolic diseases. The PPP has four specific
aims to achieve these goals: 1) To enhance the PPP developed during Phases 1 and 2, with continued
emphasis on soliciting and identifying a diverse group of promising investigators whose research focuses on
cardiorenal and metabolic diseases for mentoring and funding to expand the critical mass of extramurally
funded CMDRC investigators; 2) To provide rigorous ongoing evaluation of the progress of individual PPP
awardees and the overall PPP to maximize the impact on the investigators mentored and funded through this
program; 3) To facilitate formation of new collaborative, multidisciplinary teams of investigators whose
complementary expertise catalyzes the development of translational projects that result in competitive, cutting-
edge multi-PI proposals for extramural funding; 4) To increase the critical mass of investigators in cardiorenal
and metabolic diseases research at UMMC and to provide mentoring and funding to increase their
competiveness for conducting extramurally funded basic, clinical and population research. Thus, the PPP in
Phase 3 will continue to provide mentoring as well as financial and developmental support for innovative
cardiorenal and metabolic diseases projects to further increase the number and diversity of funded CMDRC
researchers.

Public health relevance
PILOT PROJECTS PROGRAM NARRATIVE Cardiovascular and metabolic diseases are significant problems affecting the health of Mississippians. The Pilot Project Program (PPP) seeks to develop the next generation of researchers investigating cardiovascular and metabolic diseases by providing them funding and mentoring. Through this program, we will increase the number of researchers in cardiovascular and metabolic diseases that will ultimately have a positive impact on the overall health of Mississippians.